Symptom Trajectories in Infants and Toddlers at Risk for Chronic Feeding Problems

Project Summary/Abstract
After discharge from neonatal intensive care, a subset of preterm and full-term infants will have elevated risk for
compromised development. An estimated 40-70% of these infants will have problematic feeding during the first
24 months. Because problematic feeding may escalate into a chronic feeding disorder, early symptom
identification is critical. Linking early physiologic symptoms of problematic feeding with subsequent behavioral
symptoms is needed to speed detection, enhance effective symptom management, and disrupt progression from
problematic feeding to chronic feeding disorders. A lack of valid assessment that accounts for normal variation
in feeding in children’s early development has impeded development of evidence to support a shift to earlier
detection and targeted care. To address this problem, our team has developed a set of progressive, valid, reliable
measures of symptoms of problematic feeding and eating skill development that can be used from birth through
early childhood, with scoring systems that are standardized by age. Two parent-report measures of the child’s
feeding environment complete the set. In the proposed study, we will use a concurrent explanatory mixed-
methods longitudinal design to prospectively follow 285 infants at risk for feeding problems from discharge from
neonatal intensive care through age 24 months. By concentrating assessments in the 1st year with follow-up in
the 2nd year, we will study symptoms of problematic feeding across a critical period of development highly
sensitive to adequate nutrition and with infants at highest risk for poor outcomes. Aim 1: Characterize children’s
symptoms of problematic feeding and trajectories of symptoms from the time of NICU discharge through age 24
months. Aim 2: Determine the relationship of child biological function evident at discharge (neonatal biological
risk, feeding skills, cardio-respiratory stability, gastro-intestinal function, autonomic nervous system regulation)
and child sex with symptom characteristics and trajectories emerging across the next 24 months. Aim 3: Describe
the child’s feeding environment (parent/family demographics; parent strategies to manage problematic feeding
symptoms; receipt of feeding specialty services; feeding impact on the parent/family) and its relationship with
problematic feeding symptoms from discharge through 24 months. Interviews with a sample subset will allow a
more contextual understanding of the child’s feeding environment. Aim 4: Determine the relationship between
symptoms of problematic feeding and child outcomes of the development of eating skills, growth, and
neurodevelopment. By improving understanding of characteristics of early symptoms of problematic feeding
during the period when feeding disorders are emerging, and through better understanding of the family dynamic
related to feeding problem development, we can determine common biobehavioral pathways in children’s
development of chronic feeding disorders, which will lay the groundwork for development of precision
interventions in future research.

Public health relevance
Project Narrative Infants who require neonatal care for serious health conditions commonly have problems with feeding that persist well into childhood. This project is highly relevant to public health because it will describe early biological and behavioral symptoms of problematic feeding that tend to progress to chronic feeding disorders. This will identify early time points for delivery of symptom-based interventions to prevent the shift to a chronic feeding disorder and promote the development of healthy feeding patterns.